Clinical Core

1. SUMMARY (Clinical Core)
In support of the goals of the National Alzheimer's Project Act, the Stanford ADRC will focus on the
Alzheimer's disease (AD) spectrum and the Lewy body (LB) spectrum of neurodegenerative cognitive
impairment. Recognizing that critical answers will emerge more readily when investigators can delve deeply
within and across multiple levels of participant data, we have adopted a strategy of deep phenotyping. Stanford
ADRC participants are characterized intensively and followed over time. The AD spectrum includes cognitively
impaired patients with AD dementia and mild cognitive impairment due to AD, as well as preclinical AD inferred
from biomarker data. The LB spectrum encompasses dementia with Lewy bodies and Parkinson's disease
dementia and Parkinson's disease patients with mild cognitive impairment. Healthy adults without cognitive or
motor impairment can serve as an age-equivalent comparison population, as an asymptomatic at-risk
population, and as a potential preclinical population in which mechanisms of cognitive aging and preclinical
transition can be studied. Within the LB spectrum, Parkinson's disease patients without cognitive impairment
serve as age-equivalent comparators and as an at-risk transitional population for the development of LB-
spectrum cognitive impairment. Stanford ADRC resources will enable the parallel study of these AD and LB
spectrum disorders. Opportunities for investigators to compare and contrast can provide unique insights into
pathogenesis, resistance and resilience, and therapeutic approaches. The Clinical Core will be responsible for
participant enrollment and for clinical, cognitive, and behavioral assessments. In support of a strategy that
emphasizes the deep phenotyping of individual participants, the Clinical Core is also responsible for
biospecimen procurement, imaging referral, and brain donation consent. It is responsible for participant
retention and for longitudinal follow-up. Most new participants in the Stanford ADRC will be asked to provide
disease-defining biomarkers measured in CSF, imaged by amyloid-PET/MRI, or both; to consent to
longitudinal follow-up; and to agree to brain donation through the Neuropathology Core. The Clinical Core will
work with other ADRC Cores to accomplish four aims focused on the AD spectrum and the LB spectrum of
neurodegenerative cognitive impairment: (1) Enroll participants into longitudinal research protocols of the
Stanford ADRC; characterize their neurological, cognitive, and behavioral status; provide consensus
diagnoses; follow participants longitudinally; and promote adherence; (2) support the efforts of other ADRC
Cores; (3) support ADRC development project grants and research needs of qualified externally funded
investigators who could benefit from Core resources; and (4) support the Research Education Component by
providing a rich training environment for medical and graduate students, residents, fellows, and junior faculty.